Diffusion Imaging in Gray Matter

DESCRIPTION (provided by applicant): Diffusion tensor imaging (DTI), with its sensitivity to microscopic variations in diffusion anisotropy (DA) in neural tissues, has generated great interest in both basic neuroscience research and clinical applications as a method that offers the potential for the non-invasive assessment of the status of neural tissue architecture. However, the standard DTI methodology, including its high angular resolution (HARDI) extensions, which utilizes a single pair of pulsed field gradients (sPFG), are predicated on the existence of voxel compositions that exhibit a macroscopic DA on the scale of the imaging resolution. This is often the case with voxels containing bundles of white matter (WM) fibers and thus DTI in WM has become a major focus of DTI research and applications. However, this is not the case in gray matter (GM) which is microscopically heterogeneous but lacks the structural coherence on the spatial scale of voxels to exhibit macroscopic DA. This has severely limited our ability to utilize the sensitivity of MRI to diffusion in the investigation of GM microstructure, which is a tissue of significant clinical interest. Recently, a novel set of MR methods based upon the double pulsed field gradient (dPFG) pairs have been investigated theoretically and verified in simple experiments to exhibit sensitivity to microscopic DA in voxels that are macroscopically homogeneous. These studies have primarily been applied to materials with microscopic pores, reflecting the focus on porous materials from which these methods developed. However, while we hypothesize that these methods have great potential for the study of GM, the great complexity of this tissue makes investigation of dPFG methods in GM nearly impossible to do analytically. Thus the goal of this proposal is to utilize our recently developed diffusion simulation platform (DiffSim), in conjunction with our recently developed theoretical framework for dPFG, to investigate the ability of dPFG methods to detect and quantitate gray matter architectural parameters and changes, and develop experimental techniques for applying these methods clinically.

Public health relevance
While diffusion tensor imaging (DTI) is a magnetic resonance imaging (MRI) technique that offers the potential for the non-invasive assessment of neural tissue structure, its usage is predicated on the existence of neuronal fibers with macroscopic organization on the scale of imaging resolution; thus its application has been almost exclusively to white matter (WM) structure and disease, to the exclusion of gray matter (GM), which is macroscopically incoherent, despite being microscopically coherent. Recently, however, a new class of diffusion sensitive MRI methods, called double pulsed field gradient (dPFG) MRI, has demonstrated a unique sensitivity to microscopically coherent tissues and thus may have an enormous impact on a wide range of clinical and basic research applications related to GM. Our goal is to use our sophisticated diffusion MRI simulation platform DiffSim to augment our theoretical studies of dPFG in GM to develop practical implementations in humans and thus provide the basis for clinical techniques that provide consistent and meaningful measurements of GM architecture and physiology.